AP-1 as a transcriptional regulator of AT2 cell reversible activation during lung injury response

PROJECT SUMMARY/ABSTRACT
Lower respiratory infections were the fourth leading cause of death worldwide for nearly twenty years, and in
2019 with the onset of the COVID-19 pandemic, respiratory infections quickly rose to the leading cause of
death in many countries killing over 5 million people worldwide thus far. Our lungs are equipped with stem cells
to help us recover from lung related injury caused by inhaling toxins and pathogens. However, like in many
COVID-19 cases, the stem cells cannot always handle the injury burden. Alveolar type II (AT2) cells are
facultative stem cells of the lung that secrete surfactant and aid with gas exchange. During injury, AT2 cells
withdraw from homeostatic quiescence to repair damage through proliferation and differentiation into alveolar
type I (AT1) cells, then revert to quiescence when the epithelium is restored. The mechanism behind AT2 cell
reversible activation is unclear. To better understand this mechanism, we modeled respiratory injury in mice
through a murine parainfluenza virus known as Sendai virus. Lineage tracing of AT2 cells and proliferation
revealed that AT2 cells not only activate to perform in situ wound repair, but also cluster and proliferate at
regions away from damage, specific to the edges of airways and vessels, as well as the most distal border of
the tissue, representing de novo growth. ATAC-sequencing was performed on AT2 cells from infected mice at
the peak of AT2 cell proliferation and in the recovery phase after returning to quiescence. AT2 cells gained
accessibility of AP-1 motifs during injury repair and subsequently lost accessibility for AP-1 motifs at recovery.
The hypothesis of this proposal is that AP-1 transcriptionally regulates AT2 cell activation to induce
both in situ and de novo repair during lung injury response. We will first identify the spatiotemporal
activation of AT2 cells during infection through lineage tracing AT2 cell proliferation and differentiation for
detection with light sheet microscopy to generate 3D images for deciphering if the proposed in situ and de
novo regions of activation are truly distinct. We will also perturb an airway stem cell population known to
contribute to in situ wound repair to study region specific changes in AT2 cell activation when airway
assistance is disrupted (Aim1). Second, we will investigate the regulatory mechanism in AT2 cell activation by
looking at the kinetics of epigenetic change over time through injury response with bulk ATAC and single-cell
mutiome-sequencing. We will also examine the role of AP-1 through AT2 cell specific conditional knockout of
FOSB to examine its impact on AT2 cell activation and repair (Aim2). This study will help characterize the
novel concept of in situ and de novo AT2 cell activation as well as the undiscovered epigenetic and
transcriptional regulation of lung regeneration.

Public health relevance
PROJECT NARRATIVE Lower respiratory infection and lung cancer are leading causes of death worldwide, with the COVID-19 global pandemic being an example of high lethality from lung disease. Alveolar type II (AT2) cells are the lung’s facultative stem cells that under normal conditions remain quiescent and assist with gas exchange, but in the case of acute lung injury, can execute and halt proliferation as needed to help regenerate tissue, while also being at risk for misregulated proliferation leading to lung adenocarcinoma. How AT2 cells fluctuate in and out of quiescence is unclear, therefore the goal of this proposal is to investigate the regulatory mechanism behind AT2 cell reversible activation to be applied in treatment of lethal lung injuries and cancer.